PULMOZYME (RHDNASE) IN RSV BRONCHIOLITIS NEEDING MECHANICAL VENTILATION

This is a pilot study to investigate the use of Pulmozyme in the mechanically ventilated patients with RSV Bronchiolitis. This is the second phase of a current study evaluating Pulmozyme's use in nonintubated patients.